Unlocking Access to Cyclopropanones as Divergent Reactive Intermediates in Synthesis

ABSTRACT
Strained cyclic compounds are often used as key intermediates in the synthesis of bio-active drugs
and natural products through strain-releasing reactions such as ring-expansion and ring-opening
processes. While small ring ketones such as cyclobutanones have found widespread applicability in
these transformations, the analogous use of cyclopropanone derivatives as substrates has seriously
lagged behind, as these compounds have long been considered unsustainable synthetic intermediates
due to their extreme strain and kinetic instability. This work proposes the use of 1-sulfonylcyclopropanols
as a general class of stable cyclopropanone surrogates in organic synthesis, unlocking access to myriad
previously inaccessible synthetic disconnections via strain-releasing reactions. These include (1)
rearrangements initiated by the addition of nucleophiles, (2) transition metal-catalyzed C–C activation
and deconstruction strategies, and (3) application of cyclopropanone derivatives as 1,1-cyclopropyl
linchpins. We have already developed an efficient enantioselective route to these compounds and have
obtained significant preliminary data in each of these types of reactions, leading to a variety of chiral
synthons difficult to access by other methods. Both the electronic and steric nature of the sulfonyl moiety
in these surrogates, which is acting here as a base-labile protecting group and conferring crystallinity to
these compounds, is found to have a crucial impact on their rate of equilibration to cyclopropanone,
highlighting their tunable reactivity and the potential for their widespread applicability as synthetic
intermediates. During the funding period and using the mechanistic knowledge acquired, this technology
leading to enantioenriched 1-sulfonylcyclopropanols will be extended to the formation of 1-
sulfonylcyclopropylamine and hydrazines as modular precursors of chiral cyclopropanimines and
hydrazones, respectively, and will allow novel access to chiral amine-containing scaffolds as well as
strained chiral carbene equivalents. We firmly believe that the stability, ease of synthesis and modular
character of these reagents will serve as a general solution to harvest the untapped versatility of
cyclopropanones and its analogues as highly reactive building blocks in synthesis. Thus, this work will
significantly expand the scope of disconnections available to chemists in the realm of strained ring
activation and functionalization, evolving these severely strained derivatives from chemical curiosities to
versatile synthetic intermediates, greatly contributing to streamline the production of biologically relevant
organic molecules.

Public health relevance
PROJECT NARRATIVE This proposal will explore the synthesis and application of 1-sulfonylcyclopropanols as stable precursors of chiral cyclopropanone derivatives in the development of biologically relevant synthetic methods, such as rearrangements initiated by the addition of nucleophiles, transition metal-catalyzed C– C activation reactions and radical ring-opening and deconstruction strategies. Moreover, extension of this approach to 1-sulfonylcyclopropylamines and hydrazines as precursors of cyclopropanimines and hydrazones, respectively, is proposed and will allow novel access to chiral amine-containing scaffolds as well as strained chiral carbene equivalents. The preliminary data presented demonstrates that the substrates studied are both more stable yet more reactive than existing cyclopropanone precursors, which have led to the discovery of unprecedented reactivity; this work will lead to novel key synthetic disconnections available for chemists to use in the production of pharmaceuticals and other biologically relevant organic compounds, and in the long-term, to the establishment of cyclopropanone as versatile high-energy intermediate applicable to bio-imaging via ‘click chemistry’.